HUMAN BRAIN FUNCTION AND DRUG ABUSE

This project aims to identify abnormalities in brain function that contribute to dependence on drugs, and to offer leads in developing new treatment modalities. Our strategies have included evaluating the relationship between cocaine craving and brain metabolism as measured using the [F-18]fluorodeoxyglucose positron emission tomography (PET) method and signs of arousal; comparing differences in the size of brain structures as they relate to substance abusers; and determining the cognitive effects of nicotine on brain function using the [0-15]-water PET to measure cerebral blood flow. Based on findings that the total volume of the prefrontal lobe was significantly smaller in substance abusers, we hypothesized that the structural deficit in prefrontal volume may be related to the poor performance of drug abusers on a task that is sensitive to orbitofrontal damage in humans. This task, the Gambling Task, requires that the subject balance short-term gains against long-term losses. Polydrug abusers (n=30) performed significantly more poorly on this task than controls (n=24). On the other hand, there was no difference between polydrug abusers and controls on the Wisconsin Card Sorting Task, a standard neuropsychological test of frontal cortical function, which is sensitive to damage of the dorsolateral prefrontal cortex. These data imply that polydrug abuse may be associated with functional deficits in specific portions of the prefrontal cortex. A new study evaluated the effects of nicotine on brain function, as measured by PET with [O-15]- water. Regional cerebral blood flow activation during a working memory task was assessed in 12 nicotine-dependent smokers who were abstinent for 12 h and in 12 non-dependent controls. In nicotine-dependent smokers, memory performance appeared to be mediated by different neural substrates than those in controls, suggesting that chronic exposure to nicotine alters cognitive strategies or neural systems subserving memory. Regional activation during performance of a working memory task (N-Back test) was increased by nicotine in controls, but not in smokers, suggesting the development of tolerance. - positron emission tomography, prefrontal cortex, nicotine dependence, memory performance - Human Subjects